PIKfyve regulates pH homeostasis and tumor growth in pancreatic cancer

PROJECT SUMMARY
The current overall 5-year survival rate for pancreatic ductal adenocarcinoma (PDAC) is 13% and it is expected
to become the second leading cause of cancer-related death. Given these poor statistics and the lack of effective
therapies, novel approaches are needed in treating this disease. Targeting metabolic pathways specific to PDAC
may be a relevant strategy in developing innovative treatments. Metabolic rewiring and nutrient scavenging,
which support cancer cell proliferation and survival, contribute to disease aggressiveness in a tumor
microenvironment that is poorly vascularized, nutrient-poor, and immunosuppressive. PIKfyve, a FYVE-finger
containing phosphoinositide kinase, has been associated with membrane homeostasis and vesicle trafficking,
where it is essential in driving endocytic maturation through the phosphorylation of phosphatidylinositol 3-
phosphate (PI3P) to PI(3,5)P2 on endosome and endolysosome membranes. PIKfyve has been demonstrated
to be a potential therapeutic target in multiple cancers including prostate, liver, and multiple myeloma but has
not been comprehensively evaluated in PDAC. Pharmacological inhibition of PIKfyve is achieved via treatment
with the small molecule apilimod, which has been shown to be cytotoxic in some cancer cells. This proposal
evaluates PIKfyve as a therapeutic target in PDAC by assessing PIKfyve function on cell fitness and
aggressiveness in vitro and evaluating the therapeutic effect of PIKfyve inhibition in vivo. My preliminary data
suggest that inhibition and genetic knockdown of PIKfyve reduce PDAC cell proliferation and the effects are
accompanied with the loss of pH homeostasis and blockade of macropinocytosis, a protein scavenging pathway
active in PDAC. I will determine the mechanism by which PIKfyve activity contributes to cell fitness, metabolism,
and aggressiveness. Moreover, the effect of PIKfyve on PDAC development will also be evaluated in vivo,
expanding on preliminary studies in which PIKfyve inhibition reduced PDAC tumor size in an orthotopic
syngeneic mouse model. The potential synergy of PIKfyve inhibitors with mechanism-specific drugs will also be
evaluated in vivo. Combined, this study will provide mechanistic evidence and preclinical support for PIKfyve as
a target in PDAC, potentially providing benefits to PDAC patients in the short-term since PIKfyve inhibition is
currently being tested clinically for other indications.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to evaluate PIKfyve, a FYVE finger-containing phosphoinositide kinase, as a new drug target in the treatment of pancreatic ductal adenocarcinoma (PDAC), which currently has a 13% five-year survival rate and lacks effective therapies. PIKfyve inhibition has been demonstrated to have anticancer activity in multiple preclinical and clinical studies but has not been evaluated in PDAC. Overall, this study will establish the therapeutic potential and underlying mechanism of targeting PIKfyve in PDAC, for which novel therapeutics are urgently needed for the treatment of this deadly disease.